Defining key differences in mouse fibroblasts during digit regeneration and fibrosis

PROJECT SUMMARY
Composite tissue regeneration is very limited in mammals; however, humans and mice can fully regenerate
the distal tips of the digits following amputation. This process involves the formation of a blastema, a cellular
structure that is the source of the regenerated tissue and is integral to successful regeneration. Proximal
amputations beyond the nail do not form a blastema and result in fibrotic wound-healing. This differential
behavior makes the mouse digit tip an ideal model system to investigate the cellular and molecular factors
driving each wound-healing response and why complex regeneration is so limited in mammals. Specifically,
this project will focus on fibroblast subtypes and their role in fibrosis versus regeneration. Fibroblasts are a
major contributor to the blastema and play an integral part in fibrosis; thus, they may be a cell population
that drives the decision between fibrosis and regeneration. Our single cell transcriptomic (scRNA-seq)
analysis of the regenerating blastema revealed an extremely heterogenous fibroblast population and that
the subpopulations had distinct population dynamics and lineage trajectories during blastema formation and
maturation. I hypothesize that there are specific fibroblast subtypes that promote regeneration, inhibit
fibrosis, or both. However, no studies have performed direct lineage contributions by tracing fibroblast
subpopulations in regeneration and fibrosis. Additionally, the in vivo functional roles and importance of our
computationally defined candidate pro-regenerative genes have not been established. This project will utilize
single-cell CRISPR based DNA barcoding for lineage tracing fibroblasts at the subtype resolution (Aim 1)
and plasmid electroporation for gene delivery to functionally assess candidate pro-regenerative genes (Aim
2). Together, my two aims will provide important insight into how the fibrotic and regenerative processes are
determined in the mouse digit tip and will open additional avenues for more effective clinical treatments for
large wounds or amputations in humans.

Public health relevance
PROJECT NARRATIVE There are 57.7 million people living in the world with limb amputation due to traumatic causes with a 5-year post-amputation survival rate of only 48.6%. Thus, it is important to understand the major limitations behind mammalian composite tissue regeneration in order to develop more effective treatments for those with major wounds such as limb amputations. This project utilizes cutting edge single-cell lineage tracing and gene delivery techniques to investigate the driving forces behind fibrosis and regeneration in the mouse digit tip, a model system that has strong translatability to humans.